Thermo Scientific Orbitrap Astral Mass Spectrometer

PROJECT SUMMARY
This proposal is requesting funds to acquire a Thermo Scientific Orbitrap Astral Mass Spectrometer for the Mass
Spectrometry Facility & Proteomics Center at the Medical University of South Carolina in Charleston, South
Carolina. This instrument will support NIH-funded research in areas of cancer, immunotherapy, cardiovascular
disease, liver and digestive disease, neurological disease, and addiction. Acquisition of this equipment will
provide state-of-the-art research capabilities for our investigators and meet the growing demand for ultra-
sensitive quantitative proteomic experiments for limited sample amounts and post-translational modifications of
low abundance. This high resolution and accurate mass instrument with Quadrupole, Orbitrap, and Astral mass
analyzers exhibits 4-5x faster data acquisition rates than our current instruments improving the sensitivity,
quantitative resolution, and reproducibility of measurements. This new advance in technology will speed the
discovery of mechanisms underlying disease onset and progression and yield insights into the response to
therapeutics. The requested instrumentation is to be housed in the Mass Spectrometry Facility, a University
Shared Research Resource Facility, to provide LC-MS/MS based proteomic capabilities to investigators at the
Medical University of South Carolina and academic institutions in South Carolina.

Public health relevance
NARRATIVE This proposal is requesting funds to acquire a Thermo Scientific Orbitrap Astral Mass Spectrometer for the Mass Spectrometry Facility & Proteomics Center at the Medical University of South Carolina in Charleston, South Carolina. This instrument will support NIH-funded research in areas of cancer, immunotherapy, cardiovascular disease, liver and digestive disease, neurological disease, and addiction. Acquisition of this equipment will provide state-of-the-art research capabilities for clinical and basic research scientists with the goal of advancing patient health in South Carolina.